CORE--COMPUTING

The investigators request 70% salary for a computer systems specialist and 100% salary for a programmer/analyst to support the computational needs of the six projects and to set up and maintain a server for the program project.